Hematopoietic Stem Cell engraftment in the injured niche

Abstract:
Hematopoietic stem cell transplantation remains the only curative treatment for many patients with
hematological disease. A lack of understanding of how hematopoietic stem cells and progenitors engraft in the
regenerating marrow hampers the development of new therapies to improve transplantation efficiency,
especially when donor stem cells are limiting. A major limitation for progress was the lack of tools to examine
differentiation in situ. We have developed methods to image and fate map virtually all steps of blood cell
production in situ. The objective of this proposal is to generate an atlas of hematopoietic cell engraftment and
determine how the local microenvironment promotes engraftment.
We have found that different subsets of sinusoids and megakaryocytes identify physically distinct regions of
high or poor donor cell engraftment. We hypothesize that regions of high donor cell engraftment represent
progenitor niches that selectively promote short-term engraftment. In contrast areas of low donor cell
engraftment represent stem cells niches that promote clonal stem cell renewal and long-term engraftment.
We will test this hypothesis in two aims. In Aim 1 we will generate an imaging atlas of regenerative
hematopoiesis and test the hypothesis that progenitors and stem cells differentially localize to different bone
marrow regions. In Aim 2 we will investigate the mechanisms through which unique niches in the regenerating
microenvironment support regenerative hematopoiesis.

Public health relevance
Narrative: Using in vivo models of hematopoietic stem cell transplantation the studies will generate the first cellular atlas of hematopoietic engraftment and define the molecular and cellular mechanisms through which sinusoids and megakaryocytes differentially control hematopoietic stem cell or progenitor function during regeneration. Microanatomical definition of active niches will open translational opportunities in transplantation.